Lymphoma Antigen Density and Circulating Tumor DNA Profiling As Determinants of Novel CAR Therapies

More than 80% of patients with refractory diffuse large B-cell lymphoma (DLBCL) respond to CD19-
targeting chimeric antigen receptor (CAR) T cell therapy. Yet, 50% of these patients will relapse. CD19
antigen loss is a common mechanism for CD19-CAR therapy failure in B-cell acute lymphoblastic leukemia (B-
ALL), and similar data is now emerging for DLBCL patients. CD22 is a B-cell malignancy associated antigen
and a small Phase I trial of CD22-CAR therapy has shown promise in B-ALL even in those patients who failed
CD19-CAR therapy. Interesting, CD22 antigen escape was also seen in these B-ALL patients. In preclinical
models, high antigen density was associated with optimal CAR T cell response, however the role of antigen
density's impact on clinical response has not been fully investigated. This CD22-CAR therapy has yet to be
evaluated in refractory DLBCL patients and the role of CD22 antigen density's impact on response and relapse
is unknown. Based on these observations, Dr. Frank, an Instructor in the Division of Blood and Marrow
Transplantation at Stanford University, has proposed in his K08 application to investigate novel CAR therapies
in DLBCL patients while undergoing an intensive training program to prepare him to launch an independent
translational research program. Dr. Frank's training plan focuses on developing additional skills in clinical trial
design and management; and in gaining advanced expertise in immunology and bioinformatic methods. This
training will nicely harmonize with his three research aims. He proposes to conduct a Phase I trial investigating
the safety and efficacy of this CD22-CAR therapy in patients with refractory DLBCL. Second, he wishes to
determine whether surface antigen density impacts clinical response and relapse for patients receiving CD22-
CAR therapy and whether antigen evasion can be mitigated by a bispecific CD19/CD22-CAR therapy, currently
being investigated in DLBCL patients. Third, he desires to investigate how CAR T therapy influences
circulating tumor DNA (ctDNA) dynamics in patients undergoing CD22-CAR and CD19/CD22-CAR therapy to
optimize post-treatment surveillance strategies. As part of this third aim, he proposes to use a Stanford-
developed ctDNA technology, CAPP-Seq, to identify mutations associated with CAR therapy resistance. To
oversee Dr. Frank's training and research, he will be mentored by Drs. Crystal Mackall and David Miklos,
leading experts in CAR T cell therapy. In addition, Dr. Frank has recruited Dr. Ronald Levy, a world-renowned
leader in lymphoma and immune-based therapies, and Dr. Ash Alizadeh, a leading expert in ctDNA
technologies, to serve as advisors and potential collaborators in his training and in accomplishing his aims. In
carrying out his proposed research and training plan under the guidance of outstanding mentorship, Dr. Frank
will be equipped to compete for R01 level of funding, publish high-level papers, and to launch an independent
career leading a translational research program.

Public health relevance
PROJECT NARRATIVE Non-Hodgkin Lymphoma (NHL) will affect 2.1% of men and women during their lifetime with over 70,000 new cases diagnosed every year. This proposed research will investigate a novel immune-base therapy to treated aggressive non-Hodgkin Lymphoma. This project will investigate the basis of success and failure of this treatment and provide critical data that will optimize post-treatment surveillance strategies.